Resource Core for National Swine Resource and Research Center (NSRRC) Years 21-25

Abstract (Resource)
Established in 2003, the NSRRC is meeting the needs of the swine medical research community. The
NSRRC provides a central repository service to the swine research community by importing, storing, and
distributing swine biological resources. Not only does it assure that valuable models are preserved and are
freely available, it allows researchers to satisfy NIH requirements for resource sharing, relieves the
distribution burden from individual investigators, and provides genetic and health quality control. The
NSRRC has served the NIH swine community over the past 3 ½ years by doing the following: creating 25
new models; importing 12 new models; rederiving pigs into the high health NSRRC building; cryopreserving
gamete, embryo, and male and female somatic cell samples; distributing cells, tissues, organs or pigs to 73
investigators at 43 different institutions; providing training opportunities to undergraduates, graduate
students, resident veterinarians, and visiting scientists; and sponsoring workshops that promote the use of
pigs in research. During the funding period, the NSRRC will continue to: import existing swine models of
human health and disease; rederive pigs to eliminate pathogens and health monitoring to assure
maintenance of a specific pathogen-free status; cryopreserve and store gametes, embryos, and both male
and female somatic cells to prevent future loss of valuable models; distribute expertise, reagents, cells,
tissues, organs, and specific pathogen-free pigs; use state of the art techniques to create new genetically
engineered pigs needed by the medical research community; and serve as a site for training and
educational activities related to research employing swine models.